Cannabis for Palliative Care in Cancer: A Placebo-controlled Randomized Trial of Full Spectrum Hemp-derived CBD/THC

Project Summary
Problems with pain, sleep, and mood are common among individuals diagnosed with cancer (i.e., cancer
survivors/patients), and many are turning to cannabis for symptom relief/palliative care. Recent reviews of the
literature suggest that cannabis use can indeed provide benefit for symptoms including pain interference, pain
intensity, and aspects of mood disturbance (i.e., anxiety). Cannabis may also prove less harmful/more
beneficial than other palliative care options like opiate medications, and may reduce the use of multiple
drugs (i.e., polypharmacy). Despite these promising benefits, it is also important to consider the potential
negative effects cancer patients may experience from cannabis use, including compromised cognitive function.
Research clearly demonstrates that cannabis compromises objective functioning immediately after use,
but there is mixed evidence regarding its effects long-term. This equivocation may be due to cannabinoid
content as the main psychoactive constituent of cannabis, ∆9-tetrahydrocannabinol (THC) is associated
with memory and other cognitive impairment, but cannabidiol (CBD), a non-psychoactive cannabinoid, may
attenuate these negative effects. Such effects are especially important to consider among cancer patients who
are particularly vulnerable to cognitive deficits. Differential effectiveness of CBD versus THC versus a
combination is also evident for outcomes of sleep disturbance, anxiety, and pain. Overall, as cannabis
continues to become legally available across the US and cancer patients look to cannabis for relief, more
studies are needed to better determine the efficacy of cannabis use, the role of different cannabinoid ratios,
and what side effects may arise from its use. Existing research examines synthetic cannabinoids which are
chemically homogenous and THC/CBD isolates which are unrepresentative of the whole-plant products that
are now widely available in the United States. As such, it is increasingly necessary to conduct rigorous
experimental research using more ecologically valid forms of cannabis among cancer patients. The present
proposal seeks to utilize a rigorous placebo-controlled randomized trial to understand the effects of full
spectrum hemp-derived CBD (fsCBD; CBD that contains a small amount of THC) and broad spectrum hemp-
derived CBD (bsCBD; CBD that contains no THC) versus placebo on measures of sleep, pain, mood
disturbance, subjective and objective cognitive functioning, and quality of life. These CBD products can be
legally purchased and used over the counter across the U.S., so the results of this study have immediate
application to and importance for cancer patients and their clinicians. The project aims are to 1) compare the
effects of fsCBD vs bsCBD vs placebo on sleep quality, pain intensity/interference, mood disturbance (anxiety,
depression), cognitive functioning, and quality of life over 8 weeks of sustained use and 2) compare the acute
effects of fsCBD vs bsCBD vs placebo one and two hours after use on pain intensity, current mood, and
objective cognitive task performance.

Public health relevance
Project Narrative Many cancer patients suffer from pain, sleep, and mood problems and are using cannabis to relieve these symptoms. Cannabis may provide such relief but may also produce negative side effects including cognitive impairment, an especially problematic issue for cancer patients, indicating more research on cannabis use in the cancer context is required. In this endeavor, the present study seeks to compare the use of hemp-derived CBD with and without THC versus placebo on measures of sleep, pain, mood, subjective and objective cognitive functioning, and quality of life within 185 cancer patients.